Spatial determinants in lipid metabolic organization at the sub-organelle level

Project Summary/Abstract
To adapt to metabolic cues and survive stresses like nutrient starvation, cells store high-
energy lipids in specialized organelles called lipid droplets (LDs) that emerge from the
endoplasmic reticulum (ER), the metabolic center of cells. Recent studies reveal that
LDs serve many roles in cell physiology, but how they are functionally ear-marked for
specific tasks is unclear. Indeed, the ER network itself executes numerous cellular
functions, but how this functional diversity is mechanistically achieved is unclear. The
purpose of this grant is to dissect the molecular mechanisms by which LDs and
the ER network achieve functional diversity at the sub-organelle level. Capitalizing
on published and preliminary data, we find that LDs exhibit unique surface proteomes
that provide functional specificity for LDs within single cells. Furthermore, we find that
inter-organelle contact sites define ER sub-domains with specific roles in the
compartmentalization of mevalonate metabolism. Here, I outline three directions that
enable the mechanistic dissection of LD and ER functional compartmentalization:
1) In direction 1, we will leverage yeast genetics, biochemistry, and metabolic
dissection to dissect how yeast ER-lysosome contacts (called nucleus-vacuole
junctions, NVJs) serve as ER sub-domains and “metabolic platforms” that spatially
compartmentalize mevalonate metabolism, and promote metabolic remodeling
during glucose starvation.
2) In direction 2, we will capitalize on a large-scale screen to dissect how LDs are
labeled with specific proteins to enable unique roles within cells.
3) In direction 3, we will utilize state-of-the-art cryo-FIB-SEM imaging to dissect how
lipid phase transitions within LDs selectively remodel the LD surface proteome, and
ultimately influence LD function and LD inter-organelle contact sites.
Collectively, these directions will provide insights into new cellular organizational
principles that enable to LDs and the ER network to achieve a functional division-of-
labor. They will also characterize lipid phase transition properties of sterols, which
promote disease pathologies in obesity, heart disease, and atherosclerosis.

Public health relevance
Project Narrative Cells store lipids in specialized compartments called lipid droplets (LDs), which have numerous roles including energy reservoirs and platforms for metabolic reactions. LDs are made at specific sub-regions within the endoplasmic reticulum (ER), the metabolic center of cells, but how LDs and the ER network organize themselves to achieve all of their diverse functions is mechanistically unclear. This work will dissect how LDs and the ER network spatially compartmentalize their metabolic reactions, and achieve the functional diversity necessary for cells to maintain homeostasis, which is defective in disease states such as heart disease and atherosclerosis.